The Role of Intermediate Conformations in G Protein-coupled Receptor Signaling

Project Summary
This NOSI response is an instrumentation request for a Nicoya Surface Plasma Resonance (SPR) equipment
that will supplement the parent award (5R01GM149659-02) and will foster the parent award research scope and
have long-term impact on the research in my lab in the study of both ligand-receptor and receptor-transducer
interactions. In the parent award, we created a series of conformation-biased mutants that can populate different
conformational states, ranging from the inactive state S1 to the fully activated state S5, that lie along the GPCR
activation process into different mutants, a result that has allowed us to study the function and structure of each
individual conformation. Specifically, we can trap an intermediate state S4 into a single point mutant R291A and
two conformational states S3 and S5* into a double mutant R291AR293A. These progresses allow us to study
the roles of intermediate states S3 and S4 in the signaling, in reference to the fully activated state S5. Of note,
S5* state is a pseudo-active state, in which two intermolecular salt bridges are knocked out due to the R to A
mutagenesis, distinct from the real S5 state. Most recently, we also made progress in resolving the first
intermediate GPCR- mini-Gasbg complex. The requested equipment acquisition will add a digital tool to study
the interactions between the S3/S4 states and Gasbg without a specific labeling (e.g.,19F-labeling for NMR and
isotopic-labeling for GDP and radioligand binding assays). The SPR will also help us to study the kinetics of
nucleotide exchanges in the G proteins that are regulated by different conformational states. All noted
experiments are in the scope of the proposed parent award. Furthermore, given our current work on multi-GPCRs,
the equipment acquisition will significantly elevate our lab’s capacity to screen drugs for different physiological
GPCRs and interrogate the interactions of receptors with different downstream transducers, including various G
proteins, GRKs, and b-arrestins in the future.

Public health relevance
Project Narrative G protein coupled receptors (GPCRs) are targeted by more than 30% of FDA approved drugs. Understanding the interactions between ligands, receptors, and transducers, including G proteins, GRKs, and b-arrestins, are important for drug developments. The acquisition of this proposed equipment will not only enhance our capacity of investigating the interactions between ligands, different conformational states of the A2AR receptor, and G proteins that are proposed in the parent award, but also expand our ability to study other GPCRs and their interactions with various molecules in the future.